The Effect of Myopia on Retinal Ganglion Cells, Astrocytes and Vasculature, and its Relationsip to Glaucoma Susceptibility

Project Summary/Abstract
This proposal presents a four-year Research Career Development program focused on
understanding the mechanisms by which myopia increases glaucoma susceptibility. The
candidate is currently a Clinical Instructor/PhD candidate with 80% protected research time, who
was the first to complete the combined Residency/PhD program at the SUNY College of
Optometry. The proposal builds on the candidate’s previous clinical and research experience in
ocular disease, myopia, and glaucoma, and integrates her mentors’ unique fields of expertise.
Under the guidance of her primary mentor and co-mentors Drs. Alexandra Benavente-Perez,
Stewart Bloomfield, Miduturu Srinivas and Suresh Viswanathan, she will gain a deeper
understanding of cellular and electrophysiology methodologies applied to this proposal. The
research plan proposed will provide a distinctive set of multidisciplinary skills to develop the
candidate into an independent investigator in the translational research field of myopic
complications, in particular glaucoma.
Myopia is projected to become a public health crisis that will affect half the world population by
2050, and is characterized by excessive eye growth that can affect the structure and function of
vital cells that form the retinal neurovascular unit. Glaucoma is a multifactorial blinding disease
estimated to affect more than 120 million people worldwide by 2040. While strong evidence
confirms that myopic patients are at higher risk of glaucomatous degeneration, the mechanisms
behind this association are unknown. Our current understanding of this relationship has two major
gaps: 1) the longitudinal effect that myopic eye growth and stretch have on the cellular structure
and function of ganglion cells, glia and vasculature remains unknown, and 2) there are no non-
human primate (NHP) animal models that combine myopia and glaucoma to study how myopic
progression predisposes the retina to glaucomatous remodeling. I hypothesize that myopia and
glaucoma are linked via the effect that myopic stretch has on the neurovascular unit. The overall
goals of this proposal are to define the longitudinal effect that myopia has on 1) retinal ganglion
cells, 2) astrocytes and 3) associated vasculature, and their relationship with glaucoma
susceptibility. This proposal is innovative because it focuses on studying longitudinally three key
neurovascular elements affected by myopia, using a novel NHP experimental model with anatomy
and physiology comparable to the human eye, and induced with myopia and subsequently
glaucoma. This research will have a direct positive impact and is significant because it is expected
to provide strong evidence of the unknown nature of the myopia-glaucoma relationship.

Public health relevance
Project Narrative Myopia and glaucoma pose significant public health concerns - half the world’s population is projected to be myopic by 2050 and glaucoma is estimated to affect more than 120 million people worldwide by 2040, which in turn will increase the global prevalence of myopic glaucoma significantly. Evidence shows that myopic patients are at higher risk of glaucomatous degeneration, however the mechanisms behind the myopia-glaucoma association remain unknown. The proposed research aims to identify the effect of myopia on three retinal neurovascular cell types crucial for ganglion cell survival, and their relationship with glaucoma susceptibility, in a novel non-human primate model of myopia that will be subsequently induced with glaucoma.